Hematopathology Diagnosis

Dr. Pittaluga and I aid in the diagnosis and classification of reactive and neoplastic lymphoproliferative disorders, immunodeficiency states, and diverse hematological malignancies. We provide consultative and collaborative services to physicians in the NCI, as well as to physicians studying patients with hematolymphoid disorders in other institutes, in particular NIAID, NHLBI, NHGRI, and NIAMSD. We regularly present at conferences sponsored by clinical branches in the NCI and other Institutes (NIAID, NHLBI, and NHGRI.) We receive more than 2000 cases in consultation each year. We try to restrict consultations to difficult or challenging cases, and do not accept cases for "routine second opinions". A significant proportion (approximately 25 %) of the cases are submitted by other academic institutions based on diagnostic uncertainty, or because of differences of opinion among several institutions. We are often the final arbiter on challenging diagnostic problems. Additionally, we have made novel observations based on our clinical practice, and a number of publications have emanated from case material originally reviewed in consultation. Our clinical consultation practice also synergizes with other NIH clinical groups, enhancing referral to NIH clinical protocols. Our work has led to improvement in the diagnosis and classification of several rare diseases including multicentric Castleman disease, KSHV- and EBV-associated proliferations, novel forms of both B-cell and T-cell lymphoma, and the expanding spectrum of histiocytic neoplasms. We have helped to define the differences between lymphomas occurring in adults from those in the pediatric age group. We have studied the difference between nodal and extranodal lymphomas. This work has advanced our knowledge regarding the classification of lymphoid and histiocytic neoplasms. Our work has contributed to the discovery and definition of newly emerging and rare diseases. Among these are pediatric-type follicular lymphoma, ALK-positive histiocytosis, Indeterminate dendritic cell histiocytosis, anaplastic large cell lymphoma, EBV-related T-cell and NK-neoplasms, and subcutaneous panniculitis-like T-cell lymphoma.